Identifying mechanisms by which metformin regulates T cell responses in obesity

PROJECT SUMMARY
Obesity is associated with chronic inflammation and an impaired immune response to infection from select
viruses, including influenza and SARS-CoV-2, leading to increased morbidity and mortality. Many studies have
demonstrated a critical role for CD4+ and CD8+ T cells in this setting, with primary and memory T cell responses
to viral infection impaired in mice and humans with obesity. Given the high prevalence of obesity and viral
infections with influenza and coronavirus worldwide, it is critically important to understand T cell dysfunction in
obesity and identify novel strategies to improve T cell responses to infection in this high-risk population. T cell
function and metabolism are closely linked, and many studies have demonstrated that changes to CD4+ and
CD8+ T cell metabolism influence T cell fate and function. We have found that activated CD4+ T cells from obese
mice have an altered metabolic profile characterized by increased glucose uptake and increased mitochondrial
oxidation. This represents a unique cellular metabolic phenotype that may mechanistically explain obesity-
associated T cell dysfunction. Interestingly, weight loss was unable to normalize adipose inflammation, reverse
altered T cell metabolism, or improve the impaired immune response to influenza in obese mice. In contrast;
systemic treatment of obese mice with metformin reversed CD4+ T cell metabolic dysfunction and improved
survival following influenza infection. The clinical relevance and importance of this finding are supported by
multiple observational and retrospective studies over the last few years showing that patients taking metformin
have reduced disease severity and mortality to both influenza and COVID. Multiple lines of evidence point to a
key role for metformin in regulating T cell immune responses. First, metformin has been found to alter the gut
microbiome, which we know to influence both tissue-specific and systemic inflammation, and thereby influence
T cells indirectly. Second, metformin has been shown to attenuate several inflammatory diseases by regulating
the balance of regulatory and effector T cells. Third, we have generated preliminary data in our lab showing that
metformin decreases oxidative metabolism, as well as the production of inflammatory cytokines in activated
CD4+ and CD8+ T cells and differentiated Th1 and Th17 cells in vitro, indicating a direct effect of metformin on T
cells. Therefore, the overall objective of this proposal is to elucidate the mechanisms by which metformin
regulates T cell metabolism and function, directly and indirectly, using mouse models and human samples. To
do so, we will perform the following aims: (1) Identify changes in gut microbiome and inflammatory cytokines in
obese mice treated with metformin and determine if these changes drive T cell responses; (2) Determine the
molecular mechanisms by which metformin directly affects T cell metabolism and function; and (3) Test if
treatment with metformin can reverse obesity-associated dysfunction in human T cells. Successful completion
of these aims will identify mechanisms by which metformin regulates T cell metabolism and function and reveal
novel targets to improve treatment to viral infection in patients with obesity.

Public health relevance
NARRATIVE Patients taking metformin have decreased morbidity and mortality to select viruses, including influenza and SARS-CoV-2, the virus that causes COVID-19. Using both mouse models of obesity and human samples, we propose to elucidate the mechanisms by which metformin improves immune cell responses to viral infection. Successful completion of these studies will reveal novel targets to improve treatment for viral infection in patients with obesity and open new avenues for drug discoveries in treating an increasingly obese population vulnerable to a wide variety of infectious diseases.